Multi orientation Quantitative Susceptibility Mapping for Accurate Quantification of Iron in Hemorrhagic Myocardial Infarction

ABSTRACT
Congestive heart failure(CHF) following Acute Myocardial Infarction (AMI) has emerged as a
critical contributor to the rising incidence of heart failure. Today, post-MI CHF affects 2.1 million
Americans and causes a concerning 300,000 fatalities every year. Recent studies have
established that hemorrhagic myocardial infarction(hMI)-induced intramyocardial iron deposition
can cause augmented reperfusion injuries, prolonged myocardial inflammation, and adverse
ventricular remodeling that leads to CHF. More importantly, studies have shown that iron
depletion therapies can deter these adverse effects and facilitate positive post-MI recovery. This
underscores the urgent need for reliable, noninvasive quantification of intramyocardial iron
content that can monitor the longitudinal progression of cytotoxic iron, guide the development of
novel iron-targeted therapies, and facilitate individualized hMI treatment plans for improving its
long-term outcome. However, due to technical limitations, the current standard method for
cardiac iron imaging (R2* cardiac MRI) has limited accuracy for iron quantification in hMI hearts.
Quantitative Susceptibility Mapping (QSM) MRI has recently been developed as a powerful tool
to quantify iron. QSM can directly measure tissue iron content through its underlying magnetic
susceptibility, which is resistant to confounders in the conventional R2* measurements, making
it the clinical standard for iron assessment in the brain. Despite its benefits, QSM faces
significant technical challenges when translating to infarcted hearts. These challenges include
vulnerability to unstable vital motion, elevated water content from myocardial edema,
compromised by the strong off-resonance artifacts at heart-lung interfaces, and deconvolution
errors in hemorrhagic lesions. Here, we propose to develop and validate a fast, free-running,
motion-robust, confounder-resistant cardiac QSM technique to provide reliable and consistent
iron quantification in infarcted hearts. We will test its precision under animal models with
controlled myocardial iron overload and establish its accuracy against high-resolution mass
spectrometry imaging in hMI animals. Culminating this research would transform the clinical
care for MI patients by (1) establishing a fast, non-invasive, quantitative mean for assessing
intramyocardial hemorrhage, (2) facilitating the ongoing development of novel iron-targeted
therapies, and (3) enabling individualized management planning, and ultimately improving its
long-term outcome.

Public health relevance
NARRATIVES: Congestive Heart failure(CHF) following myocardial infarction(MI) has emerged as a major driver for the rising incidence of heart failure(HF). This proposal aims to enable a reliable, free- running cardiac Quantitative Susceptibility Mapping (QSM) technique for myocardial iron content quantification in infarcted hearts. Ensuring speed, adaptability, and accuracy, this proposal can provide the foundation to develop iron-targeted cardioprotective therapy, facilitate individualized post-MI management plans, and reveal new susceptibility-sensitive biomarkers to improve the overall care for cardiovascular diseases.